The Heparan Sulfate Landscape in Complement Regulation

PROJECT SUMMARY
The complement system is a complex cascade of proteins that bridges innate and adaptive immunity
by circulating in the bloodstream and rapidly initiating and amplifying an immune response when
pathogenic material is identified. Discrimination between pathogenic material and host tissue is a vital
function for maintaining a healthy immune system. Tissue-specific damage that is driven by
complement activation and subsequent protein deposition at the tissue surface is characteristic of
complement-mediated diseases. One of the key protectors of complement activation on host tissue is
the Factor H protein (FH). FH can bind both heparan sulfate and sialic acid in the glycocalyx of
glycoproteins and proteoglycans that covers most cells. FH inactivates complement component C3, a
central protein that drives complement activity. FH is a member of a protein family composed of an
additional five FH-related proteins (FHRs). Although these FHR proteins carry highly similar heparan
sulfate-binding domains, FHR proteins counteract the regulatory mechanisms of FH and promote C3
activation and amplification of the complement response. Heparan sulfate and sialic acid have been
appreciated as key drivers of host recognition, but their specific interactions and their relative
importance is not well-defined. Heparan sulfate is a highly diverse polysaccharide that varies in
composition across tissues. Sialic acid is a single sugar molecule that is often found on terminal
residue(s) of larger asparagine- or serine/threonine-linked glycans on glycoproteins and gangliosides.
The central focus of this project is to define the contribution of heparan sulfate to the tissue-specific
regulation of complement, using a combination of biochemical, cell biological and genetic models in
mice. We will (i) use in vitro biochemical and cellular models to define binding affinities of FH and
FHR proteins for heparan sulfate and to quantify complement activation on the cell surface when
heparan sulfate or sialic acid biosynthesis is disrupted, (ii) examine the impact of heparan sulfate on
complement activation in a murine model of FH deficiency, which in humans results in complement
activation and chronic inflammatory diseases, such as C3 Glomerulopathy and Age-Related Macular
Degeneration; and (iii) determine the effect of recombinant heparan sulfate oligosaccharides as
agents for sequestering FH or FHR proteins and altering tissue-specific complement regulation both
in vitro and in vivo. These studies address the central theme of this request for applications focused
on tissue-specific regulation of complement activation and host recognition. Defining the role of
heparan sulfate in complement regulation could open the door to a new class of therapeutics that
would significantly impact a number of human diseases.

Public health relevance
PROJECT NARRATIVE The central goal of this project is to examine the relationship between heparan sulfate and local complement regulation mediated through the Factor H family of complement regulatory proteins in a murine disease model caused by Factor H deficiency. A long-term goal is to harness this information to develop heparan sulfate oligosaccharides and modified forms of heparin as agents to alter complement regulation in inflammatory diseases. This project will lay a much-needed foundation and develop a set of tools that will be used to build a more complete picture of how complement is regulated and how heparan sulfate may be a modulator of complement-mediated human disease.